Data Coordination Core

PROJECT SUMMARY
The Kids First Data Coordinating Core (DCC) supports the data intake, management, and release for the
largest pediatric genomic resource available to the public. This currently includes 40 projects, 48,000
genomes, and 23 released studies as well as other relevant interoperable datasets. The DCC is responsible for
ingestion, harmonization, curation and provisioning data to the Kids First Data Resource Core (DRC) in
lossless and high utility formats. This includes retaining source data and requisite metadata for scientific
discovery across a wide range of cancer and birth defect research domains. Through this experience, we have
developed the Kids First “Data Tracker” application as a key tool for collaboratively working with data
generators, analysts, investigators and NIH program staff for effective data coordination. The DCC will expand
the application based on the use cases around clinical data ingestion, AWS S3 storage management, status
reporting, workflow automation and dbGaP submissions. The data exchange endpoint between the DCC and
DRC will be a FHIR service and provide the ability for other interoperable data resources to integrate with Kids
First data. We will continue to improve on our genomic data best practices and expand the portfolio of pipelines
available for long-read sequencing, epigenomics and other data modalities as required for the Kids First
community. All bioinformatics pipeline development will leverage our experience building community-based
best practice workflows utilizing Common Workflow Language (CWL) and Docker so that they can be
reproducibly used by the community. Similarly, the DCC will continue to expand and improve on the
clinical/phenotypic data collection by building a standards-based curation toolkit that integrates with the Data
Tracker application. As the collection of Kids First variants scales to the level of tens of billions of variants, the
DCC will help support the community by building out easy to use workflows for variant filtering and incorporate
more expansive annotation that will allow researchers to more easily identify variants and clinical data of
further interest and investigation. The DCC will work hand in hand with the Kid First Administrative and
Outreach Core (AOC) to provide technical user support, training and other documentation to support the use of
the data, pipelines and other tools developed for Kids First to help empower and accelerate research and
discovery in the scientific community.